Using the ACS to Introduce Demographic Approaches in Undergraduate Courses

ABSTRACT
This renewal project builds on the successful first five years of progress during the initial award, which focused
on utilizing American Community Survey (ACS) data and curricular materials to introduce demographic
perspectives to undergraduates in a wide spectrum of courses. This project will make ACS-based curricular
materials available to undergraduates in many undergraduate courses in order to expose them to demographic
approaches as applied to different subject areas, as well as to pathways toward careers in population related
fields. The ACS, as a successor to the US Census long form, provides the potential for undergraduates to
explore a wide range of topics. Through this exploration, undergraduates encounter demographic
perspectives, in a way that will familiarize them with frameworks, concepts and analysis techniques commonly
utilized by demographers, thus exposing them to the field of demography in courses whose content they do not
necessarily associate with population studies. This renewal project will update and expand the creation of data
and curricular materials that are accessible to undergraduates, by working directly with undergraduate
teachers in workshops and follow up webinars, and by enhancing our general use web instructional materials.
Further, in response to requests by earlier participants and reviewers, it will broaden the training opportunities
by introducing an advanced analysis tier of training for teachers interested in accessing ACS data with more
sophisticated software and web portals. In addition, by working with graduate training population programs
and the faculty teacher network, the project's website and staff will provide information to interested
undergraduates about graduate training and careers in the population field and work actively to connect them
with those opportunities.

Public health relevance
PROJECT NARRATIVE This project introduces undergraduates who may enter a variety of careers to the underlying demographic social, economic and health dynamics that are impacting society - broadening the base of general knowledge about demographic factors which affect the health and well-being of the population at large. The project will also serve to recruit undergraduates to population and health related careers.